The role of the proximal nephron in salt-sensitive hypertension

The dramatic rise in U.S. fructose consumption mirrors the increase in the incidence of hypertension. More than
17 million Americans consume >20% of their calories as fructose and crossover studies directly show that
fructose increases blood pressure (BP). We reported that fructose causes salt-sensitive hypertension while
glucose does not. We also showed that dietary fructose enhances the stimulatory effect of angiotensin II (Ang
II) on proximal nephron Na reabsorption, the only nephron segment able to reabsorb and metabolize fructose.
We show here that dietary fructose enhances the ability of Ang II to stimulate protein kinase C (PKC) activity and
O2- production by proximal tubules. However, the roles of PKC activation and oxidative stress in the proximal
nephron in fructose-induced hypertension are poorly understood. In addition to reabsorbing ≈70% of the filtered
Na and water, one of the primary functions of the proximal nephron is to secrete proteases that degrade filtered
proteins so they can be reabsorbed. Protease-induced activation of the epithelial Na channel (ENaC) in the
collecting duct causes Na retention and hypertension in several pathological conditions. Heretofore proximal
tubules have not been thought of as a potential source for urinary proteases. Oxidative stress stimulates protease
release from non-renal cells. Here we show that dietary fructose enhances proximal nephron expression of two
such proteases, trypsin and meprin β, and augments the urinary excretion of these and urokinase. We also show
that inhibition of ENaC reverses fructose-induced hypertension. Phospholipase D and increases in intracellular
Ca (Cai) are involved in the secretion of many proteins, and both are stimulated by Ang II. Thus, we hypothesize
that dietary fructose causes salt-sensitive hypertension by enhancing Ang II-induced increases in PKC activity
and oxidative stress in the proximal nephron. This increased oxidative stress stimulates trypsin, urokinase and
meprin β expression and release from this segment. These proteases cleave and activate ENaC in collecting
ducts, stimulating Na reabsorption. Aim I will test whether dietary fructose enhances the ability of Ang II to
stimulate PKC activity and O2- production by proximal tubules thereby contributing to salt retention and elevations
in BP. Aim II will test whether dietary fructose enhances the expression and release of trypsin, urokinase and
meprin β by proximal tubules via O2-, phospholipase D and Cai-dependent mechanisms. Aim III will test whether
fructose-induced trypsin, urokinase and meprin β release from proximal tubules augments Na reabsorption by
collecting ducts, thereby contributing to salt retention and elevations in BP. We will use state of the art techniques
in imaging, physiology, molecular biology and gene transfer. This project will yield new insights into how dietary
fructose causes salt-sensitive hypertension, and which drugs currently used to treat hypertension such as Ang
II receptor blockers and diuretics targeting collecting ducts will likely be most efficacious. Since these drugs are
currently approved for such use, the recommendations could be adopted immediately.

Public health relevance
PROJECT NARRATIVE Consumption of sugars, and specifically fructose, has increased dramatically over the past several years. Fructose consumption causes high blood pressure, liver failure, kidney damage and diabetes. Fructose increases salt reabsorption by the kidney; however how it does so is poorly understood. It is also unknown whether the effects of fructose on the kidney cause high blood pressure. This proposal will study these problems.